Meningeal lymphatic dysfunction in traumatic brain injury: roles in disease pathogenesis andlong-term outcomes.

Project Summary/Abstract
Traumatic brain injury (TBI) has emerged as a leading cause of death and disability. It results in a heightened
risk for long-term disease sequelae including Alzheimer’s disease (AD) and chronic traumatic encephalopathy.
Despite being a growing medical issue, the biological factors that promote central nervous system (CNS)
pathology and neurological dysfunction following TBI remain poorly characterized. Recently, the CNS lymphatic
system was identified as a critical mediator of drainage from the CNS to the periphery. In comparison to other
peripheral organs, our understanding of how defects in lymphatic drainage from the CNS contribute to disease
is limited. It is still unknown how TBI impacts CNS lymphatic function and whether disruptions in this drainage
pathway are involved in driving TBI pathogenesis. In preliminary studies, I found that even mild forms of brain
trauma cause severe deficits in CNS lymphatic drainage that can last out to at least two weeks post-
injury. Moreover, I observed that pre-existing CNS lymphatic dysfunction mediated by targeted photoablation
before TBI leads to increased neuroinflammation and cognitive deficits. Given these preliminary findings, I
hypothesize that CNS lymphatic dysfunction contributes to TBI pathogenesis by promoting sustained
inflammation in the brain and that impairments in this lymphatic system contribute to amyloid beta (Aβ) build-up
in mouse models of AD. In Aim 1, I will use surgical, behavioral and imaging techniques to determine whether
pre-existing lymphatic dysfunction contributes to increased inflammation in the brain and adverse long-term
behavioral outcomes. In Aim 2, I will utilize lymphatic modulating techniques in a mouse model of AD to assess
whether CNS lymphatic dysfunction after TBI results in buildup of Aβ in both the brain and meninges and whether
boosting lymphatic function is able to decrease Aβ deposition in the brain. Collectively, this proposal will provide
new insights into the consequences of CNS lymphatic dysfunction in TBI, shed light on the mechanisms behind
why TBI results in a higher risk for neurodegenerative disease, and offer potential therapeutic options to target
the CNS lymphatic system after TBI.

Public health relevance
Project Narrative Each year over 2 million individuals suffer from traumatic brain injury (TBI), yet it is unknown why TBI results in debilitating long-term sequelae including chronic traumatic encephalopathy, depression, and dementia. In our preliminary studies we find that TBI results in long-lasting impairments in central nervous system (CNS) lymphatic drainage, and our early work suggests that disruption of this CNS drainage system can negatively impact disease outcomes after TBI. This project may shed light on new avenues for treatment and management through CNS lymphatic system modulation that could minimize negative outcomes.